Elucidating the Role of SMAD4 in Colorectal Cancer

Project Summary/Abstract
Colon cancer is the 2nd-leading cause of cancer-related deaths in the United States and is one of the best-
characterized solid tumors in terms of its common genetic mutations. However, knowledge gaps exist in the
basic understanding of these cancers downstream of their genetic profile. For instance, the tumor-suppressor
gene SMAD4 is mutated in approximately 57% of all colon tumors, and is associated with poor prognosis in
patients, yet there is still little understanding of its molecular mechanisms in colon cancer. Additionally,
while ~70% of colon cancers follow the typical WNT-driven adenoma-to-carcinoma pathway, approximately
20% follow the “serrated tumor pathway”- often driven by gain-of-function BRAF mutations and have the worst
prognosis of colon cancers. The proposal’s main objective will focus on elucidating the mechanistic role of
the tumor suppressor SMAD4 in colon cancers. The hypothesis is that SMAD4 plays a critical transcriptional
regulatory role in regulating the WNT pathway and is a key regulator in the serrated tumor pathway. The
rationale is based on preliminary studies that reveal: 1) that SMAD4 binds to regulatory regions of the genome
also bound by ß-catenin – the transcriptional effector of the most commonly mutated signaling pathway in
colon cancer, the WNT pathway; and 2) SMAD4 loss, when combined with activation of BRAF, can trigger
serrated tumor formation as rapidly as 1 month in mice. Aim 1 will use epigenomic approaches to map the
interaction of SMAD4 with ß-catenin at the level of DNA-binding - detailing the first intersection of these
pathways on the colon cancer genome. Aim 2 will use new mouse models to determine how SMAD4
suppresses the serrated cancer transition from hyperplastic lesions to dysplasias. Aim 3 will use state-of-the-
art tumor organoid model systems to determine how SMAD4 suppresses serrated cancer metastasis. The goal
is to test the hypotheses that 1) SMAD4 directly regulates the WNT-signaling pathway by redirecting ß-catenin
to tumor-suppressive gene targets in coordination with RUNX3, thus impacting cancer development, and 2)
that SMAD4 suppresses key signaling pathways that are required for serrated tumor progression and
metastasis. The proposed studies are significant in that they will identify the regulatory targets of a commonly
mutated tumor-suppressor gene and present a new perspective on an understudied, but more deadly, colon
cancer tumor type. These studies would have broad impacts in the cancer research field, and will reveal new
targets to identify and treat patients with serrated tumors. With the co-mentorship of Drs. Michael Verzi and
Ronald Hart, this proposal's training plan will prepare me for a transition to independence by 1) continuing to
enhance my epigenomics skillset, 2) develop novel model systems to address critical questions in the colon
cancer field, and 3) fortify the skills required to establish and maintain my own independent research program.
The Department of Genetics at Rutgers University has been an outstanding institution for my postdoctoral
training, and I will benefit greatly from the environment as I transition towards independence.

Public health relevance
Project Narrative Colorectal Cancer is the 3rd most prominent cancer found in men and women, and is the second leading cause of cancer-related deaths in the United States. My proposed research aims to dissect the molecular pathways that regulate colon cancer progression and metastasis. I hope that these studies will indentify new molecular targets that translate into new, more effective treatments for cancers.